The effect of pet dog ownership on empirical measures of child activity

Project Summary Weight management and sedentary lifestyles are of growing concern for public health in the United States with nearly 32% of children ages 2-19 classified as either overweight or obese. Further, over 70% of children fail to meet recommendations for moderate to vigorous physical activity. Walking and playing with pet dogs, however, may be a protective factor against sedentary lifestyles by encouraging walking and other physical activity. Pet dogs may be particularly important in increasing physical activity given that 51% of homes with children have pet dogs. Our long-term goal is to evaluate a causal model of canines influencing children’s physical activity and evaluate intervention and prevention efforts to increase physical activity in children. Our objective here, is to use objective accelerometer measures of physical activity to evaluate the effect of pet dogs on children’s overall physical activity (PA) and moderate to vigorous physical activity (MVPA). Using continuously worn accelerometers on children with and without dogs we will evaluate whether pet owners engage in more PA. One innovation of the proposed study is to use an accelerometer on the dog, allowing for periods of synchronized activity, such as walking the dog or playing with the dog, to be objectively quantified with a novel measure of Dog Associated PA. The specific aims of this project are to (1) determine whether a pet dog in the home is associated with physical activity in children (compared to children without a pet dog), (2) identify the amount of physical activity a child engages in that is directly related to the dog (Dog Associated PA), and (3) evaluate the association between child attachment to their pet dog and Dog Associated PA. The outcomes of this project will evaluate the potential of pets to increase physical activity in children and develop needed objective measures for studies evaluating canines’ impacts on owners’ physical activity.

Public health relevance
Project Narrative Children fail to meet national recommendations for physical activity, which is associated with an individual’s risk of chronic illness and obesity. This study investigates whether owning pet dogs increases physical activity, measured by objective continuously worn accelerometers on children aged 8-12, who do not have a dog in the home, who do have a dog in the home, and on the dogs to identify periods of mutual activity with the child. To investigate the effect of pet ownership on physical activity, we will compare activity of dog owners to non-dog owners, and using the canine accelerometer data, we will quantify the physical activity directly associated with canine activity and identify whether the child-dog bond is associated with increased physical activity with the dog.